Evaluating a Mechanistically-Supported Pharmacotherapy to Treat Acute and Protracted Opioid Withdrawal

There is substantial need to improve treatment for opioid use disorder (OUD). Buspirone is a mechanistically
supported medication with robust preclinical and preliminary clinical support for treating opioid withdrawal and
decreasing relapse. Buspirone has the utility to treat both acute and protracted withdrawal periods. We are
experts in the measurement, evaluation and treatment of opioid withdrawal symptoms and have recently
completed an RCT pilot study (n=16) which provides the initial safety, feasibility, and efficacy data to support a
more thorough evaluation of buspirone to mitigate withdrawal when administered as an adjunct to a residential
stepwise opioid taper. We propose a rigorous, Phase II, three-group, placebo-controlled double-blind RCT to
evaluate the efficacy of buspirone for (1) acute withdrawal as an adjunctive pharmacotherapy to a residential
opioid stepwise taper and (2) protracted withdrawal during an outpatient phase following taper completion.
During the 12-day residential phase, 100 participants with OUD will be enrolled, stabilized on morphine,
undergo a morphine stepwise taper, and complete a post-taper observation period where they will have the
opportunity to initiate long-term buprenorphine or extended-release naltrexone. The outpatient phase will take
place over the course of a 4-week period and will consist of weekly in-person visits and daily diary reports of
their withdrawal and craving severity and anxiety. Individuals with OUD (n=100) will be randomized to one of
three groups (1) buspirone during both residential and outpatient phases, (2) buspirone during the residential
phase and placebo during the outpatient phase, and (3) placebo during both the residential and outpatient
phases. We aim to complete 90 participants (30/group). We will collect measures of withdrawal, craving
(acute and tonic), anxiety, medication acceptability, and biochemical measures of opioid use. Primary Aim 1
evaluates the impact of buspirone on acute and protracted withdrawal. We hypothesize participants who
receive buspirone during both the residential and outpatient phases of the study will have the lowest overall
opioid withdrawal severity. Primary Aim 2 evaluates the impact of buspirone on acute and tonic craving.
We hypothesize participants that receive buspirone during both residential and outpatient phases will have the
lowest tonic craving and that participants will show significantly lower acute craving when they are actively
receiving buspirone. Primary Aim 3 evaluates whether retention and relapse prevention are impacted by
buspirone. We hypothesize that buspirone used during a residential opioid taper will increase treatment
retention and that buspirone used during the outpatient phase will decrease rates of relapse. Primary Aim 4
evaluates whether buspirone mitigates anxiety during residential and outpatient treatment for opioid
use disorder. We hypothesize that buspirone will show modest reductions in anxiety during residential and
outpatient treatment. This study will collect the data needed to determine whether buspirone is an effective
method for improving treatment outcomes for OUD during acute and protracted opioid withdrawal periods.

Public health relevance
Untreated opioid withdrawal and craving leads to poor treatment retention and high rates of relapse among those seeking treatment for opioid use disorder. Opioid withdrawal and craving are influenced by transmitter systems (dopamine, serotonin) that may not be fully treated with existing medications. We will evaluate whether buspirone (Buspar), an FDA-approved medication that acts on these systems, mitigates withdrawal and craving during residential and outpatient treatment.